Molecular and Cellular Oncology Program

ABSTRACT
Overview and Goals: The goal of the Molecular and Cellular Oncology (MCO) program is to perform in-depth
mechanistic studies in pursuit of critical basic science knowledge that can be applied towards effective cancer
prevention, diagnosis, and treatment. The expertise of program members is broad and deep, with major strengths
in genome instability, gene expression and epigenetic regulation, DNA damage responses, telomeres, pathways
controlling cell fate, and elucidation of cancer-relevant molecular structures. Research Highlights: Bench-to-
bedside team science uncovered metabolic vulnerabilities of leukemia stem cells and contributed to a new
therapy combination of BCL-2 inhibitor Venetoclax with standard chemotherapy that produces deep and durable
remissions (Cancer Cell, 2018 [1,2]; Nature Medicine, 2018 [3]) and the finding that adding autophagy inhibitor
chloroquine to BRAF inhibitor vemurafenib reduced inhibitor resistance for brain cancer patients (Elife, 2017 [4];
PNAS, 2018 [5]). Program Activities: To accomplish its goals, MCO co-leaders employ resources provided by
the University of Colorado Cancer Center (UCCC) to encourage and enable intra- and inter-programmatic
collaborations through organization of annual retreats and technology forums as well as fostering transdisciplinary
collaborations. Assisted by UCCC support, the co-leaders catalyze new research by MCO members through the
creation and expansion of Shared Resources (SR), by providing pilot funding to use these technologies, while
leveraging resources and research strengths of collaborating institutions. Through coordinated transdisciplinary
collaborations between MCO members and translational/clinical research programs, the discoveries made in
MCO move from bench to preclinical investigations and clinical trials, which ultimately improve diagnosis,
treatment, and prevention of cancer. Members: The program has 56 full and 13 mentored members with $ 4.7M
NCI and $9.0M of other cancer peer-reviewed research funding. Members are from 13 basic science and clinical
departments at UCAMC, UCB, CSU and National Jewish Health (NJH). Since July 2016, MCO members
published 476 cancer-focused publications, of which 245 (51%) were either inter-programmatic (45%), intra-
programmatic (17%), or both (11%); (27%) were in journals with an IF ≥10; and 130 (27%) represented
collaborations with investigators at other NCI cancer centers. Future Directions: Through retreats/forums, seed
grants, and support of relevant SRs, MCO plans to enhance current strengths in the cross-cutting research
themes cancer and metabolism and cancer and aging. To promote collaborative translational research of
relevance to the catchment, MCO members are collaborating with the UCCC Office of Community Outreach and
Engagement to mine patient databases from the Colorado Center for Personalized Medicine for cancer-relevant
genomic information in underserved populations in Colorado. Findings will be shared with MCO members to
stimulate catchment-relevant cancer research. These efforts will advance the discovery of basic cancer
processes and their translation into improved cancer prevention and treatment.